Investigating FGF Signaling Dynamics in migrating cells

Project Summary
Signaling dynamics are tightly regulated in space and time to control cell migration, proliferation, and
differentiation. A comprehensive understanding of how extracellular inputs influence downstream signaling and
cell behaviors will first require the ability to visualize key endogenous signaling proteins, cell architectures, and
cytoskeletal regulators in vivo. Second, it will be essential to utilize precise tools to manipulate protein
localization and signaling activity to reveal mechanisms. To explore how secreted signaling proteins disperse
and modulate cell behavior, we are using a type of C. elegans muscle progenitors (SMs) as a tractable model
for in vivo cell biology. The SMs migrate from near the tail of the worm to the center during larval development
and are a classical system to investigate cell migration mechanisms. SM migration requires Fibroblast Growth
Factor (FGF) signaling, which has been hypothesized to act as a long-range chemoattractant. However, the
key molecular and cell biological mechanisms that translate FGF signaling into directed migration are not
known. FGFs are often thought of as diffusible signaling proteins that can form gradients through free,
extracellular dispersal, but this phenomenon has never been demonstrated for an endogenous FGF. To
investigate how FGF proteins move between cells to regulate SM migration, I have tagged the endogenous
FGF ligand and receptor involved in SM migration with fluorescent proteins and imaged their localization in
vivo. Unexpectedly, I did not observe a gradient of FGF protein during SM migration, but instead observed low
levels of FGF expression in a line of ventral midline cells that are located near migrating SMs. The proposed
work builds on these findings and other new tools that I have made to visualize and manipulate key FGF
pathway proteins in order to understand how FGF signaling regulates cell migration. Aim 1 will characterize
endogenous FGF dynamics in a living animal and test how FGF moves between cells in vivo using genome
engineering and live imaging approaches. Aim 2 will investigate how migrating cells respond to extracellular
FGF by testing the extent to which FGF is a permissive or instructive signal, characterizing spatial organization
of intracellular signaling downstream of FGF, and testing functions for localized pathway activation using
optogenetics. These experiments will provide novel insights into how secreted signaling proteins move
between cells and how migrating cells interpret and respond to dynamic extracellular cues.

Public health relevance
Project Narrative Cells use signaling proteins to communicate during development, and abnormal signaling through the same pathways is frequently implicated in human diseases and disorders. This project will utilize novel genome engineering, live imaging, and optogenetic approaches to investigate core mechanisms of cell signaling by elucidating how a Fibroblast Growth Factor protein moves between cells and guides cell migration. By revealing mechanisms underlying these processes, we seek to uncover fundamental insights into how cells send and receive spatial information that orchestrates development.